Nanotherapeutic strategies for the treatment of chronic Chagas Disease

PROJECT SUMMARY
Chagas disease (CD, American trypanosomiasis), caused by the protozoan parasite Trypanosoma cruzi (T.
cruzi), is a serious public health problem throughout the western hemisphere in need of new treatment strategies
The parasite has broad tropism, capable of infecting nearly any nucleated cell and allowing formation of parasitic
reservoirs (especially in adipose tissue) that create a chronic risk of parasite reactivation. Chronic Chagas
cardiomyopathy (CCC) manifests in approximately 1/3rd of infected individuals and is the leading cause of
infectious myocarditis in the world. A need therefore exists for a strategy to selectively and locally inhibit
inflammation in heart tissue that does not interfere with systemic immunity and synergizes with current Chagas
drug regimens. Of note, Nifurtimox and Benznidazole (Bz) have been the mainstay of T. cruzi infection treatment
for decades, despite their often severe toxicity and lack of efficacy in the treatment of CCC. Thus, the objective
of this proposal is the development and validation of nanotherapies engineered to address 3 key issues for
treatment of the chronic phase of CD. 1) Treatment of CCC without impacting parasitemia or parasite reservoir
stimulation. CCC is associated with a localized pro-inflammatory, often autoimmune, response in the heart that
necessitates an anti-inflammatory treatment strategy. But such a regimen risks activation of T. cruzi tissue
reservoirs by decreasing adaptive immunity against the parasite. Thus, anti-inflammatory or tolerogenic
strategies are needed that work within the boundaries of this complex immunoregulatory environment to
simultaneously reduce cardiomyopathy and parasitic burden. 2) Targeted elimination of parasite reservoirs within
adipose tissue, which is the primary reservoir for the majority of T. cruzi strains. A customizable therapeutic
platform is needed for the targeted elimination of specific reservoir locations supporting chronic infection. 3)
Development of a novel thiophene-based nanotherapeutic to treat Bz-resistant T. cruzi. New therapeutics with
lower toxicity and alternative antiparsistic mechanisms are needed as alternatives to Benznidazole and
Nifurtimox. We will therefore optimize a novel nanotherapeutic using patient-derived T. cruzi strains. These
objectives will be accomplished using a well-vetted, robust, and customizable nanocarrier drug delivery platform
employed by the Scott Lab at the University of Virginia (UVA) with assistance from the Nakamura Lab, which
has investigated Chagas disease biology for decades at the Universidade Estadual de Maringá (UEM) in Brazil,
an endemic location with access to clinically relevant T. cruzi strains. The following 2 aims will be achieved.
Aim 1: Validate a tolerogenic/antiparasitic combination nanotherapy to treat established CCC without T. cruzi
reactivation. SubAim1: Determine efficacy of the combination nanotherapy in multiple T. cruzi strains. SubAim2:
Enhance targeting of T. cruzi adipose tissue reservoirs.
Aim 2: Optimize a novel thiophene-loaded nanocarriers using Bz-resistant T. cruzi strains and clinical isolates.

Public health relevance
PROJECT NARRATIVE Chronic Chagas cardiomyopathy (CCC) manifests in approximately 1/3rd of individuals infected with the protozoan parasite Trypanosoma cruzi (T. cruzi) and is the leading cause of infectious myocarditis in the world. CCC is uniquely challenging for therapeutic intervention, as anti-inflammatory treatments for myocarditis can inhibit anti-parasitic immune responses and thus activate parasite reservoirs, such as adipose tissue. The objective of this proposal is to engineer, optimize, and validate novel combination nanotherapies to treat CCC.